Duke Center for HIV Structural Biology

Abstract – Overall
Approximately 40 million people worldwide are living with HIV/AIDS; however, a protective vaccine or
functional cure remain elusive despite four decades of intense research. HIV-1 evades the immune system
through its rapid structural evolution during infection and replication. The proposed Duke Center for HIV
Structural Biology will provide new insights into the dynamics of HIV-1 entry and fusion with the host
membrane, the Env-initiated immune activation of B-cell receptors, and the role of anti-Env antibodies in
blocking viral rebound. The Center will pursue structural studies that aim to 1) to develop a complete, time
resolved and atomically detailed mechanism of HIV-1 Env fusion; 2) to define BCR complex structures with
specificity of autologous (anAb) and broadly neutralizing antibodies (bnAb); and 3) to achieve an atomic level
understanding of antibody-mediated control of rebound from latent HIV-1 reservoirs. The ultimate goal of these
studies is to advance structural biology techniques and knowledge of HIV-1 Env structure-derived disease
mechanisms in HIV-1 infection and rebound. Additionally, through its Developmental Core, the Center will
provide resources and training opportunities for early career investigators and trainees who are pursuing
careers in the field of HIV-1 structural biology.

Public health relevance
Narrative Approximately 40 million people worldwide are living with HIV/AIDS; however, a protective vaccine or functional cure remain elusive despite four decades of intense research. The proposed Duke Center for HIV Structural Biology will provide new insights into the dynamics of HIV-1 entry and fusion with the host membrane, the Env-initiated immune activation of B-cell receptors, and the role of anti-Env antibodies in blocking viral rebound. The ultimate goal of these studies is to advance structural biology techniques and knowledge of HIV-1 Env structure-derived disease mechanisms in HIV-1 infection and rebound.